Clarifying the roles of glycoprotein sequence and cancer cell phenotype on the immunogenicity of ovarian cancer biomarker CA125

Project Summary
There is an unmet need for innovative molecular tools that can assist in the clinical management of high-grade
serous ovarian cancer, given that more than 220,000 women in the U.S. are living with ovarian cancer and are
at risk of recurrence. Improving the performance of validated biomarkers by reinventing their detection strategy
is a compelling and underused approach to meet this need. The serum marker CA125 plays a crucial role in
the clinical management of ovarian cancer, but, despite its importance, it remains poorly understood. The iden-
tity and location of the CA125 epitopes—detected in the clinical test—are not known. In other words, the test
that underlies vital decisions in ovarian cancer care employs a mechanism that is not understood. Prior re-
search has located the CA125 epitopes somewhere within the tandem-repeat domain of a mucin (MUC16) that
contains 19 similar but non-identical subdomains. Glycan modifications, alternative splicing of mRNA, and pro-
teolytic cleavage generate many MUC16 proteoforms. Only a subset of these proteoforms contain detectable
CA125 epitopes, whereas, in others, the epitope is masked or eliminated. As a result, only a subset of the total
pool of MUC16 molecules is detectable by the serum CA125 assay. This undercounting has potentially serious
clinical implications, including mistaken decisions about whether a patient should be treated by a gynecologic
oncologist or failure to detect early evidence of possibly treatable cancer recurrence. Without knowledge of the
CA125 epitopes, it is impossible to characterize individual variation in MUC16 proteoforms or to determine
whether MUC16 expression changes during cancer development, in response to treatment, or during recur-
rence. Importantly, serum CA125 levels in Black women have been shown to be lower than levels in white
women, but the molecular-level reasons for these racial/ethnic differences in serum CA125 are unknown. The
tests and algorithms currently in use employ a single CA125 cut-off value and do not consider racial/ethnic dif-
ference, which may result in higher rates of false negative diagnoses among Black patients. To improve the
long-term survival of ovarian cancer patients of all backgrounds, there is a vital need to improve the diagnostic
value of CA125. The central hypothesis that will be tested is that CA125 epitopes are unevenly distributed over
tandem-repeat domains of MUC16, are unaffected by glycosylation, and display differences in abundance de-
pending on the cell type that expressed the MUC16. We will pursue two specific aims: (1) Map the locations
of OC125 and M11 binding on individual tandem repeats of MUC16, and (2) Characterize the binding of
OC125 and M11 to intact MUC16 from diverse sources. Successful completion of this research will identify
the CA125 epitopes on MUC16 at the amino-acid level. This accomplishment will represent an unprecedented
level of understanding of the CA125 test. This contribution will reveal regions of MUC16 that can be more ef-
fectively detected with novel affinity reagents or non-affinity-based approaches, such as mass spectrometry. It
may also contribute to explaining the origin of racial/ethnic differences in serum CA125 levels.